Immune Response Regulation by viruses

DESCRIPTION: (Adapted from the Investigator's abstract): The 3A and 2B proteins from rhinovirus inhibit the secretory apparatus of the host cell. Rhinovirus is a major cause of respiratory problems in asthma patients, and the exacerbation of asthma by rhinovirus has been the subject of many clinical studies. Those studies reveal a correlation between the strain of virus used in the study and the conclusion drawn about the role of rhinovirus in asthma. My research will test the hypothesis that those rhinovirus strains which exacerbate asthma also fail to block protein secretion, allowing release of immune messengers and inflammation. I will use molecular genetics to test the 3A and 2B proteins from several rhinovirus strains for secretory inhibition. I will then isolate secretion-permissive alleles of 3A and/or 2B, and test them in the context of the parent viruses using reporter proteins for secretory function as well as functional assays testing cellular transport of immune messengers in rhinovirus-infected cells.